Electrochemical Fluorination for Organic Synthesis

PROJECT SUMMARY
Fluorination of an organic compound affects physicochemical properties, which in medicinal settings
perturbs pharmacodynamic, pharmacokinetic, distribution, and/or metabolic profiles both in vitro and in vivo.
Thus, the ability to selectively install fluorinated groups, such as sulfonyl fluorides (SO2F) and aryl fluorides (ArF),
under mild conditions, is essential for accessing new therapeutics and biological probes. SO2F are privileged
functional groups that act as covalent warheads to evaluate substrate-protein interactions and elucidate residues
in the enzyme binding site. As a result, this group serves as a significant tool in medicinal chemistry and chemical
biology. Furthermore, ArF are common motifs seen in FDA approved drugs and drug candidates due the ability
to improve a compound’s drug-like properties. However, the unique physical properties of fluorinated substrates
and/or reagents typically perturb fundamental organic reactivities, which can complicate synthetic sequences to
access fluorinated compounds. Thus, many routine organic reactions simply do not work in the presence of
fluorinated reagents or with fluorinated substrates. Additionally, the unique properties of fluorinated substrates
enable new reactivities that cannot be achieved by the respective non-fluorinated counterparts, which provides
opportunities to develop innovative strategies for accessing medicinally relevant substructures. In this proposal,
we aim to synthesize these fluorinated substructures using electrochemical synthesis rather than utilizing
traditional methods of synthesizing SO2F and ArF, which includes harsh reagents and expensive photocatalysts.
Previously underutilized by organic chemists, electrochemical synthesis has seen a revival within the past few
decades due to its sustainability, unique reaction tunability, and mild conditions. In the proposed research, we
aim to synthesize a more diverse scope of sulfonyl fluorides. While there have been many methods for
synthesizing aryl sulfonyl fluorides, the generation of alkyl and vinyl sulfonyl fluorides is underexplored. We also
aim to use electrochemical synthesis to create a direct method for synthesizing aryl fluorides without the need
for leaving groups. Aim 1 will deliver optimized conditions for aryl, alkyl and vinyl sulfonyl fluorides alongside
computational studies to provide insight into our proposed mechanism. Aim 2 will involve optimizing
electrochemical conditions to selectively generate ArF. Once optimized conditions are delineated, we will
generate a varied substrate scope of selectively fluorinated (hetero)arenes. Development of the proposed
strategies will enable medicinal chemists to access new and unique biological probes and therapeutics through
facile late-stage fluorination of drug candidates and yield diverse aryl, alkyl and vinyl SO2F, thus broadening the
field of both medicinal and electrochemistry simultaneously.

Public health relevance
PROJECT NARRATIVE This proposal will develop innovative synthetic methods and strategies for accessing fluorinated substructures, sulfonyl and aryl fluorides, commonly found in marketed drugs, therapeutic candidates, and biological probes. Further, the proposal will computationally and experimentally validate mechanistic hypothesis imparted by the installation of fluorinated substructures with the goal of delivering next-generation fluorinated therapeutic candidates with improved drug-like properties.